Long-term Endotypes of Prematurity Associated Respiratory Disease (LEOPARD)

Project Summary
Infants born before 28 weeks of gestation are at high risk for morbidity that often persists through childhood
in the form of asthma, alveolar disease, or pulmonary vascular disease. Bronchopulmonary dysplasia (BPD) is
the clinical description of chronic respiratory disease that is typically defined by the need for respiratory support
at 36 weeks post-menstrual age (PMA, termed “typical BPD”). This description, though, may be discordant with
later outcomes, that is, approximately 60% of babies with BPD have long-term cardiorespiratory morbidity, but
conversely, approximately 40% of infants without BPD have some long-term cardiorespiratory morbidity. Thus,
there is an unmet need to anticipate these outcomes early in the newborn period to develop precise, mechanism-
based interventions for prevention or treatment. We hypothesize that these later cardiorespiratory outcomes
represent endotypes of BPD that can be defined by key mechanistically linked gene pathways (“BPD
endotypes”). We have a unique opportunity to address the limitations of preceding genetic studies by leveraging
several cohorts of approximately 2000 former premature children who were enrolled in prospective studies in
the newborn intensive care unit (NICU), who have existing genome-wide data or DNA samples, and who are
being followed at school-age and above. Through leveraging extant data obtained through the Environmental
Influences on Child Health Outcomes (ECHO) program (n=~1500) and deeper phenotyping of a prospective
cohort of children with echocardiography and spirometry (n=~500), we will perform what we believe will be the
largest cross-cohort genetic meta-analysis that will integrate genetic networks and longitudinal data and will have
the statistical power to characterize these longer-term BPD endotypes. Our overall goals are to include genetic
variation and longitudinal clinical data in directed and agnostic fashions to address a critical gap by providing
physiologic and genetic criteria for early diagnosis of subtypes of respiratory disease. We will use a combination
of traditional genetic association approaches that focus on gene pathways rather than individual variants or
genes, as well as novel gene-forward approaches that incorporate genetic pathways to inform mechanism-based
BPD endotypes. As we try to move away from the concept of “typical BPD,” understanding the physiologic
processes resulting in these “BPD endotypes” will permit developing personalized, mechanism-specific
interventions to prevent or treat these respiratory consequences of prematurity.

Public health relevance
Project narrative: Infants born more than 3 months prematurely are at high risk for lung disease that often persists through childhood, manifests as wheezing or abnormalities in lung or heart function, and may represent subtypes of disease that cannot be discerned in the early neonatal intensive care unit (NICU) course. Genetics may play a role in contributing to these subtypes, but studies have been inconclusive because of the imprecise definition of lung disease in the NICU and insufficient numbers of participants. We are assembling almost 2000 former premature infants who were enrolled in studies in the NICU, who have genetic data available, and who are now enrolled in studies at school-age to: 1) use gene pathways to define these subtypes of lung disease; 2) predict longer-term cardiorespiratory outcomes early in the NICU course; and 3) understand the genetic mechanisms that determine these outcomes so that we might treat or prevent these lung diseases early on.